Long COVID and Post Acute Sequalae of SARS CoV 2 (PASC): Pathogenesis and Treatment

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Long COVID and Post-Acute Sequelae of
SARS-CoV-2 (PASC): Pathogenesis and Treatment, organized by Drs. Michael Holtzman, Steven Deeks, Resia
Pretorius and Catherine Blish. The conference will be held in Santa Fe, New Mexico, August 27-30, 2023.
Many infections, including SARS-CoV-2, cause an acute illness that eventually resolves, with or without injury to
host tissues. However, in some people, the acute infection triggers a chronic disease that is systemic, persistent
(months to years) and, for some, profoundly disabling. Moreover, the proportion of those who have recovered
from acute infection but then begin to develop chronic symptoms (aka, Long COVID), or some other major
complication such heart disease, stroke, or diabetes mellitus (collectively referred to as the Post-Acute
Sequelae of SARS-CoV-2, or PASC) is about 50% of this population, depending on how PASC is defined.
Therefore, this Keystone Symposia conference aims to understand the progression from acute illness to chronic
disease as well as address Long COVID and PASC, for the first time, with mechanism-based therapeutic
strategies. The conference is designed to be multidisciplinary in nature and will have representation from
distinct scientific, technological, and clinical perspectives with geographical, academic, and commercial
sector diversity. It is anticipated that this broad set of perspectives will help to foster interactions leading to
synergistic solutions to an unprecedented health care problem.

Public health relevance
PROJECT NARRATIVE Many infections, including COVID-19, cause acute illness that eventually clears up on its own with no remaining complications to the patient. However, there is a portion of the COVID-19 patient population who go on to develop chronic symptoms that last from months to years. This Keystone Symposia conference is designed to review the pathogenesis and treatment of Long COVID by bringing together scientists with broad set of perspectives to foster interactions that will lead to collaborative solutions to a unique health care problem.